Brain structural and functional abnormalities in the executive function network in children with developmental language disorder

Summary
Developmental Language Disorder (DLD) is a neurodevelopmental condition that emerges in early childhood
and persists throughout adulthood. It is one of the most common neurodevelopmental disorders with an
estimated prevalence of 7-8% which is nearly seven times more common than autism spectrum disorder. While
people with DLD have significant difficulty learning, understanding and using spoken language, they also show
impairments in other higher-order cognitive domains such as executive function, including working memory,
which typically persist into adulthood. It is therefore critical to understand the brain mechanisms underlying DLD
and how they relate to language and other cognitive impairments, as this could guide the development of novel
more-targeted interventions and improve outcomes. Until now, most research on DLD has been largely based
on behavioral tasks and cognitive assessments. While these previous studies have significantly advanced the
field, the neural bases of DLD remain largely unknown and there is currently no biologically validated model that
can explain the large range of cognitive deficits and their inter-connections reported in this population. In the
relatively few neuroimaging studies that exist, the focus has mostly been on investigating the language brain
system as the major origin of this disorder, while ignoring the role of the other brain systems. In our pilot analyses,
we found that children with DLD show brain structural and functional brain abnormalities in regions typically
supporting working memory, with them being associated with greater language impairments. We suggest that
such alterations may be related to atypical development with a lack of synaptic pruning in these regions as
revealed by thicker cortex and stronger brain functional connectivity with development, which led to greater
language deficits, in comparison to their typically developing peers. In this context, the aim of this application is
to provide, for the first time, a comprehensive view of DLD-related brain in-vivo structural, functional,
neurochemical and myelination properties in the working memory network to accurately map the neural
mechanisms underlying DLD and their relationship to language impairment, during childhood. To achieve this,
we will use advanced and cutting-edge multi-modal MRI methods in 90 children with DLD and 90 matched
typically developing children, aged 6-12 years. We will first identify atypical patterns in brain structure (cortical
thickness, subcortical volume and myelin; in Aim 1), brain functional activation and connectivity (using a working
memory task and resting-state functional MRI; in Aim 2) and GABA (using Magnetic Resonance Spectroscopy;
in Aim 3) in key regions supporting language and working memory, in DLD. Lastly, Aim 4 will provide an
integrative view of these brain features and their role to predict language impairment by conducting moderation
and mediation analyses. By mapping the brain mechanisms underlying this disorder, this work has the potential
to elucidate the origins of behavioral deficits in DLD and also provide guidance for the design of future therapeutic
interventions.

Public health relevance
Project Narrative Understanding the neural mechanisms underlying developmental language disorder (DLD) is a major public health challenge as DLD is more prevalent than autism spectrum disorder, is associated with major cognitive impairments not limited to language function, including executive dysfunction, and persists throughout adulthood. One possible reason for such negative outcomes is due to our lack of understanding of the neural bases behind DLD. This project aims to determine the mechanistic underpinnings of DLD, and how they related to language impairments, which may lead to the development of novel interventions and help improve outcomes.